Administrative Core

Project Summary: Administrative Core
The Administrative Core will coordinate all the scientific, regulatory, and external reporting activities of this U19
project. It will provide oversight for all four Research Projects and the Data Science Resource Core to ensure
that experiments are coordinated and that proposed schedules for milestones are met. The Administrative Core
will support a Program Manager who will help coordinate all scientific activities and regulatory responsi bilities.
The Core will also provide for an Administrative Assistant who will support the Project Manager and scientific
personnel. The Administrative Core will coordinate meetings between the research teams and the Data Science
Resource Core. The Administrative Core will also coordinate scientific leadership meetings between the Principal
Investigators, the Project Manager, and any consultants providing support for the project. The Administrative
Core will also be responsible for overseeing data sharing between each Research Project to ensure that all
generated data are available to all team members.